Community Engagement

COMMUNITY ENGAGEMENT SUMMARY
NMRFAM has a long history of providing service and access to new technology to the NMR community. We
continue this tradition as we move into new technology development areas. Our community engagement
efforts are broad because we propose a wide range of technology development, including sample preparation,
pulse sequence, instrumentation, and software. We are also targeting a wide user base, encompassing both
the NMR community and the biomedical research community. Our community engagement efforts reflect the
different features of each technology that influence the most appropriate dissemination mechanisms, as well as
the different expertise and needs of various groups within our projected user base.